MGNet Administrative Core

The Administrative Core of MGNet serves to support all activities of the RDCRN to optimize
clinical research performance and career enhancement activities. We do so by provision of staff
focused on facilitation of all activities related to study initiation, performance, and close out
activities. Core services for clinical research coordinator training, biostatistical analysis, clinical
trial development, and immunological investigations will be provided. The leadership of MGNet
includes the administrative coordinator, clinicians, translational scientists, immunologists, patient
advocacy group leadership, and patients. This collaborative group will provide oversight and
drive process improvement as well as develop a strategic plan to assure the long-term viability
of MGNet. Administrative Core will develop focused projects beyond those in the present
proposal to enhance clinical trial readiness beyond MGNet sites and partner with industry to
optimize the performance of MG clinical trials. The shared goals of all members of MGNet are 1)
to provide a structure to enhance discovery and validation of treatment-responsive or –
predictive markers with the ultimate goal of enhancing therapeutic development, 2) improve
clinical trial outcome measures and infrastructure, and 3) enhance the quality of clinical
research for MG. As MGNet matures, the